PHASE I STUDY OF HYCAMPTINE BY IV INFUSION 24 HOURS EVERY THREE WEEKS

To determine the maximum tolerable dose, toxicity, evidence of neoplastic activity and pharmacokinetic behavior of hycamptine given by a 24 hr. continuous infusion once every three weeks to patients.